An automatic deep learning platform for kidney transmission electron microscopy image analysis

Summary
37 million people in the US suffer from chronic kidney disease (CKD). Unfortunately, the multifaceted
burden of CKD (prevalence, morbidity, mortality, costs) is relentlessly growing. CKD progression and proteinuria,
a biomarker of this process, are associated with injury to the kidney's glomerular filtration barrier (GFB), including
the glomerular basement membrane (GBM) and podocyte foot processes (PFPs). These nanometer-scale
structures can only be resolved visually using transmission electron microscopy (TEM). TEM images of kidney
tissues are commonly used to detect morphological changes in the GFB associated with disease. In both
research and clinical settings, GBM and PFP width measurements taken from TEM images of kidney tissue are
used as image-based biomarkers - aiding the diagnosis and classification of glomerular diseases. Currently,
these imaging biomarker measurements in TEM images are performed manually, which is labor-intensive and
introduces significant inter-operator variation and bias, limiting glomerular disease research and clinical
diagnosis. At present, no tools can achieve accurate results close to manual measurements. Significant variance
across different diseases, the lack of high-quality labeled training data, high-resolution images with multi-scale
and fine-grained features, and boundary ambiguity make TEM image analysis extremely challenging for general
AI models. Thus, a specially designed narrow AI model is needed to efficiently and accurately solve these
challenges.
To fill this emerging gap, we propose a novel deep learning framework integrating self-learning and a
combined High-Resolution and Pyramid Pooling Module architecture, specifically designed to address these
challenges. Images with different magnifications generated from various institutes will be utilized to improve the
model's generalization. An independent set of manually labeled images from humans, mice, and rats will be used
to evaluate segmentation accuracy, particularly for GBM and PFPs. Considering that most biomedical
researchers and physician scientists in the kidney clinical and research community lack sufficient computational
skills or resources to execute deep learning models, our system will be designed with an intuitive and user-
friendly interface tailored to meet the needs of non-computational users. The web-based interface will be
available on publicly accessible cloud platforms for users without proper computational resources, and the source
code and instructions will be released on a GitHub repository to enable users to install the system on their
institute's internal server. In addition, with the support of pathological groups from several different institutes, we
will apply the proposed method and tool to more than 70,000 TEM images to further validate its efficacy and
generalizability.

Public health relevance
Although transmission electron microscopy (TEM) images serve as the gold standard in kidney disease diagnosis and research, manual measurement is labor-intensive and introduces inter-operator variation and bias. This project aims to develop and implement the first deep learning-based platform to automate the quantification of morphologic features in TEM images, providing practical applications for both kidney disease research and clinical settings. By leveraging our collective expertise in cutting-edge deep learning, electron microscopy, ultrastructural pathology, image processing, and web-based interface development, this project aims to expedite novel drug development for kidney disease and enhance clinical diagnosis.